SPLENDOR-NC Supplement to Develop the BRIDGES Consortium Brand Guide and Website

Project Summary/Abstract
There is an urgent need to create sustainable systems to facilitate the success of diverse faculty in the research
areas central to the mission of the National Institute of Diabetes and Digestive and Kidney Diseases (NIDDK).
The BRIDGES (Bringing Resources to Increase Diversity, Growth, Equity and Scholarship in Obesity, Nutrition,
and Diabetes Research) consortium provides pilot funding, mentorship, and career development opportunities
for diverse post-doctoral scholars and early career faculty, including those from underrepresented groups, whose
research focuses on nutrition, obesity, diabetes, and/or related conditions.
SPLENDOR-NC: Supporting, Promoting, and Launching the Expansion of Nutrition, Diabetes, and Obesity
Researchers in North Carolina is one of four programs that make up the BRIDGES consortium. SPLENDOR-NC
leverages the strong partnerships between Duke University, North Carolina Agricultural and Technical State
University, North Carolina Central University, The University of North Carolina at Chapel Hill, Wake Forest
University, and Winston-Salem State University to facilitate the success of diverse faculty engaged in fields of
research related to the mission of NIDDK.
This administrative supplement will provide resources to SPLENDOR-NC to facilitate the development of a
central BRIDGES consortium website and accompanying brand guide. The BRIDGES website will serve as a
venue to share program components and goals across consortium members, awardees, and the public. The
website will serve as a link to a collaborative workspace and central repository of materials used by consortium
members. In addition, the website will provide a platform in which to showcase scholar and pilot awardee
accomplishments, and an advertising space to promote the BRIDGES consortium.

Public health relevance
Project Narrative The goal of the BRIDGES (Bringing Resources to Increase Diversity, Growth, Equity and Scholarship in Obesity, Nutrition, and Diabetes Research) consortium is to enhance the career development, pilot funding, and mentorship opportunities for diverse post-doctoral scholars and early career faculty, including those from underrepresented groups, who intend to pursue a research career focused on nutrition, obesity, diabetes, and/or related conditions. This administrative supplement will enable the development of a new website that will serve as a digital resource for all partnering institutions of the BRIDGES consortium. The BRIDGES website will serve both as a source of information about the BRIDGES consortium and as a venue to showcase program successes and best practices.